Epithelial specific roles for GPx1 in the intestinal microenvironment

Project Summary
Antioxidant proteins which regulate reactive oxygen species (ROS) are often considered to be protective
in the setting of intestinal inflammation and disease, such as inflammatory bowel disease (IBD). Glutathione
peroxidase 1 (GPx1) is a ubiquitously expressed selenoenzyme and potent antioxidant which decreases cellular
hydrogen peroxide (H2O2). However, our previous studies using Gpx1-/- mice have indicated that unlike many
antioxidants whose loss exacerbates murine colitis, loss of GPx1 confers striking protection from dextran-sodium
sulfate (DSS)-induced colitis. Further investigation has suggested GPx1’s protective effect may be due, at least
in part, to increased intestinal proliferation and stem cell activity which may help to prevent or repair colitis-
induced injury. However, specifically testing epithelial-dependent roles for GPx1 has been hindered by the lack
of necessary mouse models, as a mouse model capable of cell type-specific deletion had not yet been developed
for Gpx1. Although we have improved our understanding of GPx1’s epithelial roles by use of ex vivo intestinal
organoids, which indicate that the observed changes in intestinal cell growth are epithelial-cell intrinsic, our
reductionist models cannot truly investigate the contribution of these findings to a complex, multifaceted disease
setting such as that observed during IBD.
To address this need and better leverage our previous research results, we have now generated a novel
Gpx1 floxed mouse model. These mice have subsequently been crossed with the Vil-CreERT2 line, allowing us
to restrict Gpx1 loss to intestinal epithelial cells. For the first time, these mice will allow us to specifically
investigate GPx1’s epithelial-dependent contributions to intestinal homeostasis, stem cell biology, and
experimental colitis as implicated in our K01-funded studies. These contributions will be examined in two specific
aims. The first aim will clearly delineate epithelial-dependent versus -independent effects for GPx1 in intestinal
homeostasis, mucosal immunology, and colitis. The second aim will complement broader epithelial-based
studies by more specifically determining how GPx1 loss alters intestinal stem cell biology. This aim will also
begin to explore potential mechanisms by which GPx1 may affect intestinal homeostasis and disease, with initial
studies focused on roles in the WNT signaling pathway. Together, these studies will address a major technical
limitation, characterize novel research reagents, and provide clarity and preliminary feasibility for future studies
as we work to build upon our previous findings on GPx1 in the intestine. Thus, this award will provide greater
means to expand my independent research program focused on understanding mechanisms by which GPx1
and antioxidant proteins contribute to intestinal health and disease. As previous research has indicated that
optimal ROS levels are key to maintaining intestinal health, ultimately these studies will advance our knowledge
of IBD pathobiology and therapeutic options to reduce development, diminish severity, and promote intestinal
healing in the setting of intestinal inflammation and IBD.

Public health relevance
Project Narrative While antioxidant proteins are often thought to protect against intestinal diseases, such as inflammatory bowel disease (IBD), we have determined that loss of antioxidant glutathione peroxidase 1 (GPx1) instead attenuates experimental colitis. Under this proposal, our studies will work to investigate how GPx1 drives this protection by characterizing new mouse models which allow us to target GPx1 loss to specific cell types and biological contexts. Ultimately, these studies will grant us better understanding of the mechanisms by which GPx1 and antioxidant proteins contribute to intestinal health and the development, severity, and treatment of IBD.